Impact of state-level gabapentin schedule V controlled substance classification on utilization and fatal overdose

PROJECT ABSTRACT
Polysubstance-involved overdose rates have risen across the United States. Gabapentin, an anticonvulsive
medication with FDA-approved uses for postherpetic neuralgia and partial seizures, is a co-substance of
growing concern. Despite its limited on-label indications, gabapentin prescriptions have steadily increased,
likely driven by off-label use. Reports of recreational abuse and misuse, particularly among individuals with
opioid use disorder, are of particular concern, given that concurrent gabapentin and opioid misuse may
result in death. Gabapentin has been increasingly detected in fatal overdose toxicology, especially in the
Southeast United States. These harms have led to calls for increased monitoring or scheduling of
gabapentin. In June 2018, West Virginia (WV) became the second of eight states to classify gabapentin as
a schedule V controlled substance; however, the net effectiveness of the policy is unknown. Policy changes
concerning controlled substances, which often result in altered prescribing patterns, have the potential to
address concerns like over-prescribing and misuse but may also endanger users with dependence.
Limiting access to prescribed medications may result in a shift to alternative substances obtained from
nonmedical sources with unknown potency and potentially high levels of contaminants. This study will
utilize a controlled interrupted time series design to assess the impact of the policy in WV, using North
Carolina (NC) as a control state to account for secular changes given the lack of controlled substance
designation in that state. Using WV’s Forensic Drug Database and NC’s State Unintentional Drug
Overdose Reporting System, Aim 1 will assess whether gabapentin’s schedule V controlled substance
classification in WV was associated with a change in 1A) the rate of gabapentin involved fatal overdoses,
and 1B) the overall fatal overdose rate. Using Merative MarketScan Commercial Claims and Encounters
Databases, Aim 2 will assess whether gabapentin’s schedule V classification in WV was associated with a
change in prescription utilization among 2A) all privately-insured adults and 2B) adults with diabetic
neuropathy for whom gabapentin is clinically indicated. Using Medicaid’s State Drug Utilization Data, Aim 3
will assess whether gabapentin’s schedule V classification in WV was associated with a change in
outpatient gabapentin prescriptions paid for by Medicaid. Our longitudinal data analysis approach will allow
us to identify both immediate effects and trend changes resulting from the scheduling policy’s
implementation. As more states, as well as national policymakers, consider classifying gabapentin as a
schedule V controlled substance, it is imperative to understand the impacts of WV’s implementation, both
intended and potentially unintended. Results from this study will enhance the evidence base of
gabapentin’s schedule V classification and inform future policy discussions.

Public health relevance
PROJECT NARRATIVE Gabapentin misuse, particularly among individuals with opioid use disorder, has led to its increasing involvement in overdoses. West Virginia (WV) classified gabapentin as a schedule V controlled substance; however, the policy's effect on medication utilization and potential harms is unknown. This study will evaluate WV's policy to understand its impact on gabapentin's involvement in fatal overdose and describe its impact on prescription utilization among private insurance and Medicaid. Assessing potential unintended consequences of the policy's implementation will contribute to the national debate over federal classification of gabapentin.